Advancing Extracellular Vesicle Therapy for Brain Cancer

PROJECT SUMMARY
Engineered tumoricidal extracellular vehicles (EVs) are a promising therapy for the highly aggressive brain
cancer Glioblastoma (GBM). Round Table Research Inc. (RTR), in collaboration with Drs. Shawn Hingtgen and
Juliane Nguyen at UNC-Chapel Hill, has successfully developed the first EV drug carriers derived from induced
neural stem cells (iNSCs), a unique cell type created using novel Transdifferentiation (TD) cellular
reprogramming strategies, for GBM treatment. Building on the long-standing interest and deep expertise of our
RTR and UNC team across EV carriers, iNSC technology, and GBM therapy, we demonstrated that 1) iNSCs
produced EVs at twice the rate of parent fibroblasts; 2) iNSCs naturally loaded the pro-apoptotic agent TRAIL
throughout the lumen and outer membrane of EVs (EVTRAIL) that selectively co-localized with tumor foci and killed
a panel of co-cultured brain cancer cells; 3) the intracranial infusion of EVTRAIL therapy reduced metastatic brain
cancer 500-fold greater than free drug; 4) Mimicking key aspects of clinical EV therapy for GBM, EVTRAIL therapy
reduced tumor volumes 50-fold while extending median survival from 39 to 60 days with 30% long-term survivors
in mice bearing diffuse patient-derived GBMs. These results demonstrated that iNSC-derived EVs are a platform
for creating tumor-homing cytotoxic therapies for cancer, where the scalable, efficient, and efficacious production
could maximize treatment durability in human trials. Thus, the proposed studies in this Phase I STTR will advance
EV therapy towards the pre-IND stage. To this end, our Specific Aims are: 1) Using a scalable manufacturing
process, conduct pre-IND-enabling toxicity, biodistribution and safety studies in human GBM xenograft models
of resection/recurrent in mice; 2) Determine the efficacy of intracerebroventricular re-dosing of multi-agent EV
therapy in post-surgical models of human GBM xenografts. The metric of success of this Phase I is to 1) confirm
the efficacy of multi-drug EV therapy in a more clinically relevant setting; 2) develop an infusion, efficacy, and
safety package that will guide definitive safety/toxicity that RTR will submit to the FDA as part of an IND filing.
The Phase I mechanism is appropriate for this project, based on: 1) pre-clinical testing in multiple in vitro and in
vivo studies have shown the safety and efficacy of iNSC-derived EV therapy for GBM, 2) the proposed studies
seek to advance our approach and establish key parameters for dosing and drug composition as we work
towards definitive IND-enabling studies; and 3) the dire need for an FDA-approved product to improve the
extremely poor survival outcomes of GBM. Success of the proposed studies will further support pre-clinical
development of this innovative approach to EV therapy for GBM and ready RTR to perform IND-enabling studies
in testing in a Phase II proposal.

Public health relevance
PROJECT NARRATIVE Glioblastoma (GBM) is an incurable brain cancer where ineffective drug delivery results in rapid disease progression and patient mortality. Building on our successful work from human cells and multiple murine models of GBM, this proposal seeks to develop cytotoxic extracellular vesicles (EV) derived from induced neural stem cells (iNSC) as a new approach to GBM therapy. These studies could allow practical, safe, and efficacious iNSC- based EV therapies for GBM to become a reality, and launch the field of EVs therapies derived from cellular engineered producer cells towards improving cancer treatment.